Research Project 2

PROJECT SUMMARY
Congenital disorders of glycosylation (CDGs) are a heterogeneous group of rare inherited diseases caused by
mutations in genes involved in protein glycosylation. The most common CDG, PMM2-CDG, results from
mutations in the gene phosphomannomutase 2 (PMM2), encoding an enzyme that converts mannose 6-
phosphate (M6P) to mannose 1-phosphate (M1P). Defects in PMM2 limit the production of GDP-mannose, a
nucleotide sugar essential to synthesize precursors needed for N-linked glycosylation. Reduced GDP-
mannose causes protein hypoglycosylation and numerous clinical phenotypes. The connection between
hypoglycosylated proteins and phenotypes is unclear, creating a major gap in our knowledge of CDG
disease pathogenesis. PMM2-CDG patients exhibit variable penetrance indicating that genetic and/or
environmental factors modify disease. We characterized a zebrafish model of PMM2-CDG and identified two
classes of enzymes, the protein proconvertases (PCs) and matrix metalloproteinases (MMPs), as candidate
drivers of pathology. Analyses of cartilage defects in pmm2 mutant zebrafish revealed a block in early
chondrocyte development that is associated with defective processing of the cell adhesion molecule N-
cadherin. N-cadherin is sequentially cleaved by furin PCs and MMPs, and both exhibit altered activity in pmm2
mutant zebrafish. The proposed studies address the hypothesis that reduced glycosylation alters the
activity of PCs like furin, initiating a cascade involving MMPs that disrupts processing of key cell
adhesion molecules, including N-cadherin. We will define how hypoglycosylation of protein processing
enzymes alters tissue development; determine whether there is a common mechanism among CDG subtypes;
and identify genetic modifiers of CDG disease severity. Toward these goals in Aim 1 we will develop novel
zebrafish lines that express wild type and glycan-deficient FLAG-tagged forms of several PCs and MMP
enzymes. We will use these tools to define how hypoglycosylation of individual enzymes contributes to
impaired chondrogenesis in PMM2-CDG. In Aim 2 we will perform RNA sequencing on several zebrafish
models of PMM2, STT3A and STT3B-CDG to identify the pathogenic mechanisms and molecular networks
that are commonly or uniquely altered in CDG. Using these analyses in combination with novel Drosophila
models we will also pursue genetic modifiers of CDG disease severity. The molecular and genetic pathways
identified as sensitive to hypoglycosylation will provide foundational information to develop much needed
therapies. Further, the platform established within this proposal will create the road map to ultimately study
how disruption of other N-glycosylation genes causes disease.